Principle Research Core /DRP 1 -DRP 2

B.3.2 Principal Research Core. DRPs are designed as pilot RCTs aimed at developing procedures and data to support larger R-01 submissions for full clinical trials. DRP #1 (Yrs 3-5): TABI for the treatment of depression in adults. This project will build on an existing Internet Intervention,